Common Fund Gene Utility Compendium: A Systems Biology Resource to Explore Tissue-Specific Functional Genes and Druggable Genomes

PROJECT SUMMARY
Tissue-specific genes are underutilized as disease targets. Tissue-specific genes show narrow expression, play
key roles in maintaining tissue homeostasis and are thought to be good drug candidates. Thus, targeting of
dysfunctional tissue-specific genes can provide a safer therapeutic approach due to the reduced risk of side
effects. However, identifying which tissue-specific genes are critical in disease is a bottleneck in drug discovery.
We hypothesize that key tissue-specific genes have the ability to spread perturbations in a protein-protein
interactome and can be identified by their context specific functionality. This approach offers a paradigm shift
from conventional analyses that uniquely focus on one-gene expression levels. We recently proposed Gene
Utility Model (GUM) which hypothesizes that it is how a gene is utilized in protein-protein interaction (PPI)
network dictates its importance in disease development. We will use information flow of a gene within a PPI
network to represent the gene utility in a given biological state. Under this scenario, genes with high information
flows (i.e., high gene utilities) in a disease state, instead of gene expression level, are deemed to play more
important roles in disease development. Thus, this application seeks to increase the clinical utility of NIH
Common Funds datasets by employing state-of-the-art systems biology approaches to precisely and reliably
identifying tissue-specific druggable functional genes (TS-DFGs). We will construct a prototype for Common
Fund Gene Utility Compendium by leveraging four NIH Common Fund datasets: Genotype Tissue Expression
(GTEx), Library of Integrated Network-based Cellular Signatures (LINCS), Illuminating the Druggable Genome
(IDG), and 4D Nucleome (4DN). We will focus on three disease types, liver cancer, nonalcoholic fatty liver
disease (NAFLD), and Alzheimer's disease (AD) as proof-of-concept studies. In Aim 1, we will uncover highly
utilized tissue-specific genes across multiple normal tissue types and three selected disease types. We will then
construct utility karyotype to indicate chromosomal regions enriched with highly utilized genes. In Aim 2, we will
employ selectivity, controllability, and suitability as criteria to score druggability for TS-DFG candidates with
respect to liver cancer, NAFLD, and AD. Druggable utility networks (DUNs) with respect to each disease type
will be constructed to assess the distribution of highly score TS-DFGs in a PPI network and signaling pathways.
The constructed prototype of the Common Fund Gene Utility Compendium will promote innovative research to
enhance the usage and provide added clinical value for the NIH Common Fund datasets by offering a new
paradigm shift for target and drug discovery. Our long-term goal is to enlarge this compendium by including
more diseases across different tissue types to facilitate integrative pan-tissue analyses and drive drug
discovery.

Public health relevance
NARRATIVE Targeting tissue-specific genes is a challenging task due to their critical role in maintaining tissue homeostasis and physiology, but it can also offer an opportunity to achieve effective and safer therapeutic interventions. We propose to discern tissue-specific genes functionality and targetability in dieases by assessing their utility in biological networks. Thus, the purpose of this proposal is to increase the clinical utility of NIH Common Funds datasets by constructing a Common Fund Gene Utility Compendium and facilitate the discovery of druggable tissue-specific genes.